Leukadherins as novel compounds for treating restenosis

DESCRIPTION (provided by applicant): Percutaneous coronary intervention (PCI) is the mainstay treatment to unblock atherosclerotic arteries. Despite significant technological advances in PCI, restenosis (re-narrowing) secondary to neointimal hyperplasia remains an important cause of morbidity and death. The extent of local and systemic inflammation after PCI highly correlates with the extent of restenosis. The integrin Mac-1 (also known as CD11b/CD18, CR3, and αMβ2), which is primarily expressed on leukocytes, plays a key role in vascular injury and inflammation. Mac-1 mediates leukocyte adhesion, migration, and recruitment after vascular injury. As approaches using anti-Mac-1 blockers have had limited success in human clinical trials, in this project, we propose an alternative innovative approach for treating vasculr injury by activating instead of blocking Mac-1 with a novel class of compounds that we have termed leukadherins. We demonstrate the surprising discovery that leukadherins significantly promote endothelial re-growth and prevent neointimal hyperplasia after arterial balloon injury in rats. Our overall hypothesis is that activation of the Mac-1 receptor via leukadherins is sufficien to prevent leukocyte transmigration and activation, decreasing vascular inflammation and neointima formation. We also hypothesize that leukadherin suppress the inflammatory activation of leukocytes during the repair of the injured vasculature. We propose three Specific Aims (SA) to test our hypotheses. In SA1, we will search for molecular connections between Mac-1 activation and leukocyte deactivation after vascular injury. We will investigate the role of inflammation suppressors Akt and Syk on leukadherin's anti-inflammatory effects. In SA2, we will identify the in vivo mechanism by which leukadherins promote endothelial recovery. We will assess how leukadherins promote local endothelial cell growth over endothelial progenitor cell recruitment to accelerate vascular re- endothelialization. Finally, in SA3 we will identify the in vivo mechanisms by which leukadherins reduce neointimal hyperplasia in a clinically relevant model of in-stent restenosis. We will compare our lead leukadherin agonist, LA1, with M1/70 mAb (antagonist) in a rabbit model of in-stent restenosis, and will provide a basis for progressing to preclinical studies in larger animals (pigs) and, eventually, to clinical trials. RELEVANCE: Restenosis is the major complication after coronary interventions, accounting for $3 billion dollars in medical expenditures annually in the US alone. In this study, we will help define whether and how pharmacologic activation of integrin Mac-1 has therapeutic potential for the prevention of restenosis. This will pave the way for the future discovery of novel therapeutic agents to treat restenosis after PCI as well as other vascular inflammatory diseases. PUBLIC HEALTH RELEVANCE: Percutaneous coronary interventions (PCI) including stent placement by catheters are the most effective way to unblock coronary arteries and facilitate coronary revascularization. Despite all of the technological and pharmacological advances in PCI, vascular re-occlusion (restenosis) remains the major complication accounting for billions of dollars in medical expenditures annually in the US alone. This study will demonstrate how a novel class of anti-inflammatory compounds, leukadherins, prevents inflammation, accelerates vascular healing, and halts the re-occlusion of coronary arteries after PCI, resulting in outcomes that may represent new strategies and alternative therapies to accelerate endothelial healing and reduce the occurrence of restenosis, ultimately saving lives.

Public health relevance
Percutaneous coronary interventions (PCI) including stent placement by catheters are the most effective way to unblock coronary arteries and facilitate coronary revascularization. Despite all of the technological and pharmacological advances in PCI, vascular re-occlusion (restenosis) remains the major complication accounting for billions of dollars in medical expenditures annually in the US alone. This study will demonstrate how a novel class of anti-inflammatory compounds, leukadherins, prevents inflammation, accelerates vascular healing, and halts the re-occlusion of coronary arteries after PCI, resulting in outcomes that may represent new strategies and alternative therapies to accelerate endothelial healing and reduce the occurrence of restenosis, ultimately saving lives.